Using design thinking approaches to tailor a dyadic behavioral sleep intervention for persons living with dementia and their caregivers

Project Summary
Sleep disturbance is prevalent in persons living with mild cognitive impairment or early-stage Alzheimer’s
disease and related dementias (PLwCI) as well as their caregivers. This prevalence suggests that sleep
disturbance is an interdependent process that synergistically affects both members of the caregiving dyad.
Sleep disturbance is associated with poorer health outcomes, including higher depressive symptoms and lower
quality of life. Cognitive behavioral therapy for insomnia (CBTI) is effective for improving sleep disturbance in
many populations, and support from a partner during CBTI results in more successful outcomes. The
interdependence of PLwCI-caregiver sleep disturbance suggests the need for a dyadic intervention. However,
there are no structured fully dyadic interventions focused on managing sleep disturbance in PLwCI and their
caregivers; moreover, no dyadic interventions have been developed with input from these stakeholders.
Aligned with the National Institute of Aging’s Behavioral and Social Science and Neuroscience high-priority
dementia caregiver research agenda, the proposed K23 Patient-Oriented Mentored Career Development
Award seeks to use design thinking, human-centered approaches within the CBTI framework to tailor a dyadic
intervention (T-Dyadic Sleep) for PLwCI and their caregivers. Twenty PLwCI-caregiver dyads and 10
healthcare providers will be interviewed during the tailoring phase. We will then conduct a waitlist randomized
control trial (N = 40 dyads) to test the acceptability, feasibility, and preliminary immediate and sustained
efficacy (3 months) of T-Dyadic Sleep. The completion of this mentored research project will enable me to
acquire foundational knowledge for conducting large-scale intervention trials and fulfill the need for effective
dyadic interventions to treat sleep disturbance in PLwCI and caregiver dyads. The interdisciplinary training plan
and goals developed for this K23 award will fill a critical gap in my current skill set. Building on my training as a
clinician with expertise in sleep and dementia caregiving, I will develop proficiency in 1) design thinking
approaches, 2) dyadic theories, concepts, and analytic methods, 3) identification and diagnosis of dementia-
related disorders, including a focus on how these disorders relate to sleep disturbance, and 4) scientific writing,
oral presentations, manuscript development, and peer review. I have assembled an excellent team of mentors
(Drs. Hepburn, Barton, Lyons and Lah) and a collaborator (Dr. Gehrman). The K23 award will provide me with
the necessary foundation to build a successful and independent program of research related to sleep,
dementia, and caregiving. My program of research aligns well with NIA’s Strategic Directions for Research to
understand and develop interventions to address the needs of patients living with Alzheimer’s disease and
related dementias as well as the needs of their caregivers, and to engage persons living with dementia and
their caregivers as part of research teams.

Public health relevance
Project narrative Sleep disturbance in persons living with dementia and their caregivers is a significant public health burden which is associated with depressive symptoms and poorer quality of life. We will use design thinking, human- centered approaches to tailor a dyadic behavioral intervention for sleep disturbance for persons living with mild cognitive impairment or early-stage Alzheimer’s disease and related dementias and their caregivers; then, we will conduct a waitlist randomized controlled trial (N = 40 dyads) to examine the intervention’s acceptability, feasibility, and preliminary efficacy on individual and dyadic objective and subjective sleep outcomes. The findings of the proposed project will inform future larger-scale clinical trials and can provide a novel and innovative method for persons living with mild cognitive impairment or early-stage dementia and their caregivers to achieve better sleep and quality of life outcomes.